COMPLIANCE AND CONTROL IN CHILDHOOD DIABETES

The purpose of this study is to delineate which adherence behaviors are important to good diabetic control in adolescent populations and the conditions under which they exhibit their strongest impacts.